Administrative Supplement to: Decoding mechanotransduction mechanisms of cell-surface receptors

PROJECT SUMMARY
This supplement project is to support Erin Nolan in a PhD trainee and career development training experience
alongside the goals of R35GM119483. Erin's mentoring and career development plan will enhance her
organizational, writing, and presenting skills as well as provide ample opportunities to explore a variety of long-
term career goals in biomedical research. Erin will engage with her mentors, Dr. Gordon and Dr. Largaespada,
in weekly research and career development discussions. She will work on a research project to test the
hypothesis that increased Ras signaling leads to increases in forces cells exert on their surroundings using a
high-throughput assay based on DNA tension probes developed by the Gordon lab. She will also explore how
cellular forces exerted by cells correlate with other cellular phenotypes to begin to address the broader
question of how genetic changes in a cell contribute to cellular mechanical phenotype, and vice versa.

Public health relevance
PROJECT NARRATIVE An explosion of recent studies has indicated that altered mechanical forces in a cell’s environment is a potentially targetable and quantifiable factor in disease, much like mutations in DNA or proteins, which makes intui-ive sense given that cancer is often diagnosed by detecting a lump that feels harder and stiffer than the sur-rounding tissue. Understanding how cell-surface proteins sense and respond to force will result in new therapeutic avenues and diagnostic tools for diseases like cancer, heart disease, muscular dystrophy, and polycystic kidney disease.